Regulation of chronic obstructive pulmonary disease by parsnip polyphenols

PROJECT SUMMARY
This proposal introduces a novel dietary approach targeting chronic obstructive pulmonary disease (COPD)
caused by air pollution. Respiratory disorders, including asthma, COPD, and lung cancer, are significant global
health concerns with high mortality rates. The primary risk factor for COPD is the inhalation of air pollutant
cigarette smoke, leading to chronic pulmonary inflammation, mucus hypersecretion, airway remodeling, and
emphysema, all contributing to lung dysfunction. Unfortunately, there are currently no effective medicinal
therapies or dietary interventions for COPD. Cigarette smoke (CS) constitutes of over 7000 chemicals with known
93 harmful and potentially harmful chemicals such as acrolein. Repeated long-term environmental exposure to
CS activates reactive oxygen species, inflammatory-oxidative stress and apoptosis that leads to alveolar space
enlargement and development of COPD-emphysema, as well as compromising the ability to fight infection in the
lungs, ultimately resulting in respiratory failure. Therefore, novel approaches that improve mitochondrial function
in the lungs of COPD patients are urgently needed. Recent studies have indicated a potential protective effect
of raw parsnip root (Pastinaca sativa), in combination with celery, against acrolein-induced pulmonary damage
and inflammation. Moreover, our preliminary data demonstrate that an aging process involving high-temperature
post-harvesting leads to the generation of polyphenol-enriched parsnip with enhanced antioxidative capacity
compared to raw parsnip. We have observed that this aged parsnip effectively reduces lung inflammation and
damage in mice acutely treated with acrolein intranasally. Based on these findings, we hypothesize that aged
parsnip is a safe and bioactive dietary compound that can protect lungs from the pathogenesis of CS-induced
COPD. To test this hypothesis, two aims have been developed using an animal model of chronic CS inhalation
and primary human normal bronchial epithelial cells. Aim 1 will define the role of aged parsnip in chronic CS
exposure-induced COPD. Aim 2 will determine the mechanism(s) underlying aged parsnip-ameliorated COPD.
Successful completion of these aims will enable us to define the novel function of polyphenol-enriched aged
parsnip and its bioactive components in air pollution-induced COPD.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) induced by environmental and air pollutants globally contributes to mortality and chronic morbidity. This project aims to investigate the novel role of aged parsnip in cigarette smoke exposure-induced COPD. Ultimately, the knowledge gained from this project will serve as the foundation for developing drugs or lead molecules based on aged parsnip for treating COPD.